Understanding developmental control of cell polarity using single-cell in vivo biochemistry

Project Summary / Abstract
Cell polarity is a fundamental feature of eukaryotic cells, and must be coordinated between cells and regulated
to allow for normal animal development and tissue homeostasis. Despite genetic identification of proteins
involved in cell polarity and a large body of knowledge about their interactions in vitro, it remains unclear how
polarity proteins are organized into signaling complexes in cells. This lack of knowledge has prevented the field
from understanding mechanisms of developmental control of polarity signaling in vivo.
The long-term goal of the proposed research is to resolve the network of protein-protein interactions that
supports animal cell polarity and to understand how this network can respond to developmental signals. To
enable progress towards this goal, the applicants have developed innovative experimental tools that allow
single-molecule measurements of native protein complex abundance in single cells. This project focuses on an
evolutionarily conserved protein kinase, called aPKC, that plays a central role in polarity by localizing to one
end of a polarized cell and dictating polarized cell behaviors. The applicants will make use of the C. elegans
early embryo, in which cells reproducibly polarize in response to multiple spatial and temporal cues, to discover
mechanistic links between developmental signals and the polarity machinery.
The central hypothesis of this work is that developmental signals control cell polarity by altering the molecular
complexes in which aPKC resides. This hypothesis will be explored by elucidating mechanisms that regulate
assembly of aPKC into different complexes in the zygote (Aim 1); by determining how polarity is entrained to
cell-cell contacts in 8-cell embryos (Aim 2); and by determining how translation of new protein components
remodels the polarity system between these two stages (Aim 3). The work proposed in this application is
significant because it will reveal fundamental mechanisms controlling cell polarity, and because it places these
mechanistic studies in a developmental context. The proposed work is innovative, in the applicant’s opinion,
because it uses novel experimental methods to perform biochemical, mechanistic studies in vivo. By studying
the biochemical control of aPKC in multiple cellular and developmental contexts in a single experimental
system, this work will identify fundamental mechanisms of PAR polarity signaling and to learn how these
mechanisms are deployed to achieve different outcomes during development.

Public health relevance
Project Narrative To assemble and sustain functional tissues, cells need to establish and maintain an asymmetric organization of their membrane and cellular contents, a phenomenon referred to as cell polarity. Polarity must be coordinated between cells and controlled by extracellular signals in order for cells to behave normally; loss of this coordination is associated with developmental defects, early embryonic lethality and metastatic cancer. This proposal makes use of innovative experimental methods to study how cells polarize and how polarity is controlled during development, which is relevant to the NIGMS mission because it will increase understanding of a basic biological process and lay the foundation for advances in disease diagnosis, treatment and prevention.